J: NRSA Training Core

The purpose of our NRSA TL1 Training Core is to develop, implement and disseminate innovative educational
pipeline programs in transdisciplinary (TD) clinical and translational science (CTS), designed to launch the
careers of the next generation of diverse translational investigators. Our socially responsible and ethically-
grounded NRSA-TL1 pre-doctoral and postdoctoral trainees, equipped with epidemiology skills and data
science acumen; teaming capacity; and a health equity, community lens, will be prepared to embrace the
scientific and medical challenges of tomorrow and pursue novel healthcare solutions. As medicine increasingly
tackles previously intractable, yet common complex diseases (e.g., Alzheimer’s, diabetes, cancer, COVID-19),
transdisciplinary training in patient-oriented research needs to include data science. A deeper understanding of
data science will harness the potential of the massive genetic, epigenetic, biochemical, administrative, and
environmental data generated daily in medicine, government, science, and engineering. Our program will
catalyze the development of the next generation of leaders in CTS and TD research by building upon our
previously established CTSA-funded competency-based education programs, innovative data science
education, novel toolkit of training activities and assessments; peer/near peer mentorship program and our
highly productive and impactful Patient Oriented Research Training, And Leadership (PORTAL) program that
supports both medical students and PhD students. We will additionally leverage our innovative, highly
successful postdoctoral program-Sinai Team-based Translational Education Program: the Underrepresented in
Medicine and Science (URiMS) Propeller (STTEP-UP) initiative, a novel training effort to advance the CTS
careers of URiMS postdoctoral scientists (physicians and PhDs), previously recognized by NCATS for its work
in promoting diversity across all NIH CTSA Hubs in the common metric of recruiting and training
-
underrepresented persons. Our efforts to realize modern CTS through TD research training of physician-
scientists and PhD data scientists also takes advantage of our long-standing institutional commitment to big
data research, as evidenced by our Biomedical Data Science Initiative, the Exposomics institute, the recently
launched Masters and PhD programs in Genomics & Data Science and in Artificial Intelligence, the newly
created Clinical Informatics Fellowship, as well as our proposed TD Education and Resilience Accelerators.
Our strategically aligned, stage- and learner-specific transdisciplinary training pipeline initiatives aspire to
provide novel models of successful CTS TD career development, including justice, equity, diversity and
inclusion, as we work at the collaborative interface between data science, and the health of our communities in
order to train, sustain and propel the CTS workforce of tomorrow.